Structural Biology Of G Protein-Coupled Receptors

Project Summary
G protein-coupled receptors (GPCRs) constitute the largest membrane protein superfamily in the human
genome, with over 800 unique sequences. GPCR-mediated signaling pathways play a key role in all
physiological systems as well as many pathophysiological conditions and therefore represent important drug
targets. GPCRs have a seven-transmembrane-helix (7TM) topology and contain multiple binding sites for
orthosteric ligands and allosteric modulators. Upon recognition of their native ligands receptors transmit signal
across the cell membrane to intracellular partner proteins, such as G proteins or β-arrestins. Developing a
detailed understanding of functional mechanisms of GPCRs and facilitating design of novel drugs with high
selectivity and potency require access to high-resolution three-dimensional structures, determination of which,
however, remains a challenging task. We propose here a comprehensive research program which combines
technology development with integrated structure-function studies focused on GPCR superfamily. The proposed
research directions are designed to accelerate high-resolution structure determination of membrane proteins,
improve our understanding of GPCR superfamily and answer specific questions on ligand specificity and
selectivity as well as molecular mechanisms of action using several specific receptors as targets. Our approach
integrate structural information on new receptors and complexes with data obtained from biophysical,
biochemical and functional experiments through computer-based analysis and modeling. The long-term goal of
our laboratory is to develop a deeper understanding of the molecular mechanisms of action of GPCR using the
tools of structural biology and to apply the achieved insights towards the design and development of novel and
efficacious therapeutics.

Public health relevance
Project Narrative GPCR-mediated signaling pathways play a key role in all physiological systems as well as pathophysiological conditions including cancer, immune disorders, cardiovascular diseases, metabolic disorders (e.g. obesity, diabetes), pain and addiction. Over 30% of all prescription drugs on the market act via these receptors. The structural biology study of the human GPCR family will result in developing a deeper and thorough understanding of molecular mechanisms of ligand recognition and receptor function, which should translate into development of more efficient therapeutics with diminished side effects.